Dissecting sodium appetite circuits in the mammalian brain

Project Summary
Internal sodium balance is critical for many physiological functions, including osmoregulation and action
potentials. Deciphering the mechanisms that control sodium intake is essential for understanding the
principles of appetite regulation and sodium homeostasis in the body. Our understanding of central
sodium appetite regulation is still lacking compared to other appetite circuits such as thirst and hunger. I
propose to study this fundamental brain circuit that controls our internal ion balance using transcriptomic
and molecular genetic tools. Our preliminary and published results have identified specific neural
populations in the mouse hindbrain and forebrain that acutely regulate sodium ingestion. However, it is
currently unknown how these distinct neural nodes contribute to sodium appetite. Our central hypothesis
is that distinct neural circuits regulate sodium appetite and tolerance. We will test this idea through three
specific aims. In Aim 1, we will use gain- and loss-of-function manipulations to examine if individual neural
populations control behavioral aversion and/or attraction toward sodium. This study is expected to identify
the functional roles of each genetically defined neural population in sodium ingestion. In Aim 2, we
propose to use genetics, virus tracing, and physiological recording to dissect the circuit organization
underlying sodium ingestion. Once the anatomical map is identified, we will use projection specific neural
perturbation to examine the function of the individual downstream regions. In Aim 3, we propose to
identify cell types from downstream areas of sodium appetite neurons. We will achieve this by combining
activity-dependent high-throughput single-cell transcriptomics and neural perturbation in the upstream
population. This approach is expected to dissect specific cell types that receive sodium appetite signals
from upstream neurons. We will then use genetic information of the identified downstream cell types to
examine how signals from distinct nuclei interact to drive sodium appetite. Together, this proposal will
provide critical insights into the brain-wide regulatory mechanisms underlying sodium ingestion.

Public health relevance
Project Narrative Overconsumption of sodium is a serious risk factor of cardiovascular and cognitive malfunction. This project will examine the brain circuit that mediate sodium appetite and consequent ingestion. The proposed research is relevant to public health because it will provide insights into the function and dysfunction of sodium regulatory mechanisms that optimizes dietary sodium intake.